Effects of prenatal exposures to maternal obesity and gestational diabetes on metabolic decline from childhood to adolescence and underlying neurobiological pathways

Parent Project Abstract
Rising childhood obesity rates are coupled with an alarming increase in the prevalence of type 2 diabetes in
children and adolescents. Evidence suggests that in utero exposures to maternal obesity and/or gestational
diabetes mellitus (GDM) contribute to these upward trends, and the effects of these prenatal exposures on
metabolic risk become more pronounced during adolescence. While the biological mechanisms of such
maternal-fetal programming are poorly understood, compelling studies in rodent models show that in utero
exposure to maternal obesity and/or diabetes causes abnormal development of brain pathways involved in
energy balance regulation, leading to obesity and type 2 diabetes later in life.
Our group was the first to study the effects in utero exposures to maternal obesity and GDM on brain
pathways and metabolic outcomes in humans using a pioneering approach combining neuroimaging methods
and metabolic phenotyping in children. To date, findings from our BrainChild cohort provide strong support for
the neuroendocrine programming effects seen in animal models. The earliest abnormality we have identified
involves modification of brain pathways known to be involved in energy balance regulation. These brain
modifications were predictive of increases in food intake and weight gain in children during follow-up and
support the primary hypothesis of the longitudinal BrainChild study: that differences in the neural markers
observed in children at age 7-10 will be predictive of metabolic outcomes during the transition to adolescence,
a critical time for brain development and metabolic decline.
The longitudinal Brainchild study, with follow-up to 18 years, provides the unique opportunity to
advance our understanding of the interplay among brain changes, obesity, insulin resistance and beta cell
function at early stages in the evolution of transgenerational transmission of obesity and diabetes risks. Given
the growing number of pregnancies complicated by maternal obesity and GDM, the well-being of future
generations may depend to an important degree on developing interventions that can break the vicious
transgenerational cycle of obesity and diabetes. The proposed studies will contribute critical information to the
knowledge base required for development of such interventions.
Aim 1: Examine relationships between in utero exposures to GDM and/or obesity and metabolic outcomes in
offspring. Aim 2: Determine whether neural markers associated with in utero exposures to GDM and/or obesity
will change and will be predictive of metabolic decline in offspring. Aim 3: Assess whether alteration(s) in
neural markers involved in energy balance regulation is a pathway linking in utero exposure to GDM and/or
obesity to metabolic decline during childhood to adolescence.

Public health relevance
Project Narrative The overall goal of the parent project is to assess how prenatal exposure to GDM and maternal obesity affect developmental trajectories in brain pathways and how altered developmental trajectories in brain pathways lead to altered glucose metabolism as children progress through adolescence. To extend the parent project, I will assess longitudinal trajectories in metabolic factors (adiposity, insulin clearance, insulin sensitivity, insulin secretion, beta cell function) related to the development of type 2 diabetes (T2D) and whether these key metabolic factors differ by GDM exposure, multiple social determinants of health variables and sex. Notably, this is the first study to our knowledge that will investigate how the longitudinal relationship between GDM exposure and glucose regulation differs by multiple individual and structural social determinants of health variables.